Flagellar cAMP signaling in Trypanosoma brucei

Project Summary/Abstract
Trypanosoma brucei is a flagellated protozoan parasite responsible for sleeping sickness, a vector-borne
disease that causes great human suffering and economic burden and is endemic to sub-Saharan Africa. In
addition to its own medical importance, T. brucei represents a group of related human parasites. Because of
easy genetic manipulation, T. brucei is also a valuable model organism for studying flagellum/cilium biology. To
survive, be transmitted, and cause disease, T. brucei must sense and respond to environmental signals. This
is especially important for a vector-transmitted parasite, because it must respond to multiple host
environments. Sensing is achieved by signal transduction pathways that detect external changes and convert
these into cellular responses. Little is known about these pathways and mechanisms in T. brucei, or other
related pathogens – this is a critical knowledge gap and potential source of discovery of new treatments.
Cumulative evidence shows the T. brucei flagellum is a critical platform for cAMP signaling that controls cell
movement, cell-cell communication, chemotaxis, movement through tissues, transmission through the insect
vector and pathogenesis in the mammalian host. It has also been demonstrated that the flagellum tip is an
important domain for organizing cAMP signaling, and models hypothesize mechanisms for tight control over
cAMP distribution, retaining cAMP near sites of generation and downstream effectors. Surprisingly, however,
spatial arrangement of cAMP production and propagation has been directly examined. Moreover, almost
nothing is known about effectors in the flagellum that transmit cAMP effects. Thus, fundamental questions
regarding trypanosome cAMP signaling mechanisms remain unanswered. We are well-positioned to answer
these questions by employing our state-of-the-art quantitative tools for phosphoproteomics of flagellar
subdomains, functional signaling assays, and new tools for live imaging of cAMP fluctuations inside cells. Our
specific aims are to (1) identify and functionally characterize cAMP-effectors and (2) test hypotheses for
mechanisms of cAMP signal distribution and propagation through the flagellum. To identify proteins regulated
by cAMP (1a), we established a platform to obtain the cAMP-dependent phosphoproteome and we will use this
to find target proteins altered by cAMP. For functional analysis (1b), we will examine motility and signaling in
mutants lacking the proteins or phosphorylation sites identified in part (1a). This aim will provide novel insights
into the function of individual cAMP effectors as well as the broader role of phosphorylation as a mechanism of
transducing cAMP signaling in trypanosomes. To determine distribution of cAMP, we will visualize cAMP
fluctuations using a genetically encoded FRET sensor in live cells (2a). We will use this FRET-based system to
study propagation of the cAMP signal in response to external stimuli and test tenets of the current flagellum
microdomain cAMP signaling model (2b).

Public health relevance
Project Narrative Trypanosoma brucei and related trypanosomes are deadly pathogens that cause tremendous human suffering worldwide. Transmission and pathogenesis of trypanosomes requires signal transduction systems to enable the parasites to adapt to diverse external environments in the mammalian host and insect vectors that transmit them, but the underlying signaling mechanisms are very poorly understood. cAMP signaling has emerged as an important pathway for transmission and infection by T. brucei and in the current project we will define mechanisms of cAMP signaling in these parasites.